Brain Mechanisms Supporting Mindfulness Meditation-Based Chronic Pain Relief

Project Summary
Pain is a multidimensional experience that involves sensory, cognitive and affective factors. The constellation
of interactions between these factors renders the treatment of chronic pain challenging and often a financial
burden. In fact, chronic pain affects over 100 million Americans and costs the United States approximately
$635 billion dollars a year. The widespread use of opioids to treat chronic pain has led to the so-called “opioid
epidemic” due to the exponential growth in opioid misuse and addiction. These staggering statistics highlight
the importance of developing, testing and validating fast-acting, non-pharmacological approaches to treat pain.
Mindfulness meditation is a technique that has been found to significantly reduce pain in experimental and
clinical settings. However, lack of mechanistic data and the assumption that extensive meditation training is
required to experience analgesia has limited the clinical deployment of this cost-effective and narcotic-free
treatment. Recent findings from our laboratory determined that mindfulness meditation, after only four sessions
(20 minutes/session) of training, dramatically reduces pain intensity and unpleasantness ratings. Across two
functional neuroimaging studies, employing perfusion-based MRI (arterial spin labeling), we found that
mindfulness meditation reduces pain through multiple brain mechanisms related to increased cognitive control,
emotion regulation and attenuation of ascending nociceptive input. However, these results cannot be
generalized to chronic pain because they were associated with healthy, pain-free participants and thermally
induced pain. Importantly, the brain mechanisms supporting the modulation of chronic pain by mindfulness
meditation remain unknown. Thus, the central aim of the proposed R01 study is to determine the specific
mechanisms supporting the modulation of acutely exacerbated chronic low-back pain, the most prevalent and
financially burdensome chronic pain condition, by acutely trained mindfulness meditation. We will determine if
the neural mechanisms found to attenuate experimentally induced pain by mindfulness meditation (i.e., OFC,
sgACC, thalamus) are also associated with modulating chronic low back pain. The neurofunctional connections
supporting mindfulness-based pain relief are also unknown. Thus, we will also examine if mindfulness-based
pain relief is associated with thalamic-default mode network decoupling to provide mechanistic insight to better
develop interventions to target pain.

Public health relevance
Project Narrative Pain is a highly individual experience that produces incalculable suffering and a significant economic burden on millions of Americans. The research activities of the proposed R01 application will investigate the neural mechanisms that support mindfulness meditation-related chronic low-back pain relief to provide a foundation for the development of non-pharmacological and effective treatments for clinical pain.